Institutional Research Cancer Epidemiology Fellowship

This application is for a 5-year renewal (Years 39-43) of the Training Program in Cancer Epidemiology,
Prevention, and Control (T32 CA009314) at the Johns Hopkins Bloomberg School of Public Health. Our
mission is to train pre- and postdoctoral trainees to be leaders at the forefront of advancing knowledge of a)
causes of cancer, including inherent and modifiable factors in human populations locally, nationally, and
globally; b) how to prevent and reduce cancer burden locally, nationally, and globally by i) providing and
communicating a better understanding of behaviors that influence cancer development and promote healthy
survivorship, ii) identifying new markers for early detection of cancer, and iii) identifying and addressing cancer
disparities including in vulnerable populations and barriers to care; and c) how to translate, implement, and
evaluate cancer epidemiology, prevention, and control discoveries into populations. We provide a rich and
interactive environment augmented by highly innovative, productive, and collaborative cancer research
conducted at the Schools of Public Health and Medicine and Sidney Kimmel Comprehensive Cancer Center.
The Training Program provides cancer-relevant methodologic and cancer-specific substantive area research
training. 6 pre- and 2 postdoctoral trainees pursue tailored curricula with shared elements: didactic courses on
substantive and methodologic topics, responsible conduct of research, research rigor, reproducibility, and
transparency; interactive information exchange; teaching, communication, grant writing; community outreach
and engagement experience; mentored pre- or postdoctoral research; and cancer-specific professional
development. We stress developing and testing novel hypotheses and collaborating across disciplines. Via
shared elements, trainees are exposed to contemporary cancer topics such as molecular epidemiology, big
data, social justice and disparities, aging, HIV, personalized risk assessment, screening, survivorship,
implementation, communication, policy. 26 Preceptors (23% underrepresented groups, 77% identify as
women), selected for outstanding mentoring and cancer-relevant research records, are primary mentors. With
the Director, the Executive Committee is responsible for trainee selection/monitoring, and program refinement
as cancer research evolves. Internal and External Advisory Committees provide evaluation and advice.
Training duration is 4 years for pre- and 2-3 years for postdoctoral trainees. We have a strong record: 43 pre-
and 25 postdoctoral trainees in the last 15 years completed or are in training. They have had career success
(89.2% research or related). From a large pool of applicants, the best candidates are recruited. 20% are from
underrepresented groups. In summary, the Program is designed to a) provide trainees with a multidisciplinary
background essential to conduct highest caliber, state-of-the-art, collaborative, population-based foundational
or applied cancer research, b) nurture them to be innovative thinkers, c) develop teaching, communication,
grant-writing skills, d) prepare them to lead the nation's cancer research agenda in academia or elsewhere.

Public health relevance
Project Narrative The Training Program in Cancer Epidemiology, Prevention, and Control prepares pre- and postdoctoral trainees to be the next generation of population-based researchers who will set and address the nation's cancer research agenda with the goal of reducing cancer incidence, morbidity, recurrence, and mortality, and the disparities in cancer.